Pseudomonas aeruginosa Microcolony Aggregates Elicit Neutrophil Swarming

PROJECT SUMMARY/ABSTRACT
Pseudomonas aeruginosa is a ubiquitous, opportunistic bacterial pathogen adept at developing antimicrobial
resistance and capable of colonizing a variety of host tissue sites to manifest disease. The immunocompromised
lung, damaged skin from burn or injury, or scratched cornea represent vulnerable sites where P. aeruginosa
infection establishes to cause significant pathology. P. aeruginosa exhibit both planktonic and biofilm lifestyles
in the course of infection. Host cells are infiltrated by individual bacteria damaging affected tissue while
communities of bacteria emerge in extracellular space as biofilms. These colonization tactics create formidable
targets that challenge the defensive capabilities of individual neutrophils recruited as part of the innate immune
response. In turn, neutrophils have evolved a strategy of working together as a population to synergize their
collective arsenals against large target pathogenic threats that lie beyond the capacity of individual neutrophils
to phagocytose and clear. This strategy reflects an emergent property of the collective called neutrophil
swarming whereby individual neutrophils coordinate to surround a target (an area of infection or damage) so that
the swarm can isolate and neutralize the threat. A greater understanding of the cellular and molecular
mechanisms of neutrophil swarming has tremendous potential to reveal novel anti-infective therapeutic
strategies with improved efficiency geared toward harnessing the power of the swarm to eradicate intractable
infections. This proposal is timely as multidrug resistant strains of P. aeruginosa have been on the rise in recent
years and pose an increasingly alarming burden to healthcare providers. We unveil herein a novel ex vivo model
of neutrophil swarming against a laboratory cultivated large bacterial target. The bacterial target consists of P.
aeruginosa combined with agar to create beads of imbedded bacteria growing as microcolonies on the bead
surface. We demonstrate that neutrophils rapidly swarm in response to these large bacterial targets and the
swarm can temporarily restrict bacterial growth. We seek to leverage this new model to identify P. aeruginosa
and neutrophil factors that drive this multifaceted innate immune response. Our data suggests that elements of
the bacterial type three secretion system (T3SS) play a central role from the pathogen perspective. Additionally,
we will explore contributions of the neutrophil swarm amplifying agent, leukotriene B4, and mechanisms by which
it is biosynthesized by a neutrophil community in the context of swarm development. Overall, we contend that
our approach contributes a new tool for investigators to use when seeking to understand cellular and molecular
mechanisms of neutrophil swarming. In leveraging this tool, we aim to add to this knowledge base by executing
of our proposed mechanistic studies focused on both host and pathogenic factors. Results of our investigations
can serve as foundational toward development of novel anti-infective strategies that bolster host innate immune
responses rather than targeting the infecting organism, which may reduce development of drug resistance and
provide efficacy to a variety of infectious organisms with limited treatment options that cause disease in humans.

Public health relevance
PROJECT NARRATIVE Neutrophils are first responder white blood cells mobilized to limit the spread of infection. Antimicrobial agents are generally prescribed to treat infections that can overwhelm natural host defenses. Pseudomonas aeruginosa is a ubiquitous bacterial pathogen prone to developing antimicrobial resistance, leaving infected patients with limited treatment options. This proposal introduces a novel approach to model neutrophil swarming ex vivo in response to aggregates of P. aeruginosa to decipher pathogen and host factors driving the development of a neutrophil swarm. Through our discoveries enabled by this new model, we propose to unveil novel therapeutic strategies that can be deployed to improve neutrophil control of infection while minimizing collateral tissue damage.